Modeling Complex Particle Interactions in Dry Powder Inhaler Based Drug Delivery

Project Abstract
Title: Modeling complex particle interactions in dry powder inhaler based drug delivery.
Abstract: Dry powder inhalers (DPIs) are used to deliver drugs directly to human airways and
lungs, and are often used to treat medical conditions such as asthma or emphysema. The active
drug particles used in DPIs are often very small, typically less than 5 micrometers. The small
size makes them very cohesive, which reduces their flowability. Large carrier particles that
aggregate with the smaller drug particles are employed to facilitate drug delivery.
The agglomeration and deagglomeration processes that are central to DPI drug delivery are
affected by a variety of factors including inter-particle cohesion due to van der Waals interaction,
Coulombic and dielectrophoretic forces between charged particles and turbulence in the inhaler
and human airways. Accurate modeling of fluid flow and particle motion, accounting for all these
forces, is vital for thorough understanding of drug delivery using DPIs. Coulombic forces
between charged particles have been widely studied in the particle technology literature;
however, dielectrophoresis, which has been shown to play an essential role in clustering of
seemingly identical dielectric particles, has received much less attention. As the drug and carrier
particles used in DPI are usually dielectric materials, dielectrophoresis is very likely to play a
significant role in agglomeration in DPIs. Including this force in DPI analysis for the first time in
the literature would be a novel aspect of the proposed work.
The main challenge in modeling electrostatic forces between particles lies in determining the
particle charge that originates from contact charging between the particles and the device
internals. Prior DPI studies have simply specified the charges on the particles, which are usually
not known. The most widely used approach in literature to model the extent of particle charging
via contact charging employs effective work function of each material as a phenomenological
parameter to characterize charge transfer between two contacting surfaces. This approach has
been employed in the research group of the PIs to study the interplay of gas-particle fluidization
and particle charging; the proposed research would introduce this approach to DPI studies for
the first time in the literature.
In this proposal, we will develop a CFD-DEM simulation tool based on open-source platforms.
Emphasis will be based on implementing models for all the known physics, including van der
Waals force, fluid turbulence, Coulombic and dielectrophoretic forces and contact charging. The
code will be validated against experimental data from the literature and also used to perform
simulations exploring the importance of various physical characteristics of the particles.

Public health relevance
Project Narrative: The proposed research will develop a computational approach that will aid in development of improved dry powder inhalers and new drug formulations. In addition to particle size distribution, gas turbulence and inter-particle forces due to van der Waals and Coulombic interactions, the proposed work would include, for the first time in dry powder inhalation studies, dielectrophoretic forces and contact charging. The code will be validated against experimental data from the literature and also used to perform simulations exploring the importance of various physical characteristics of the particles.